CARDIOVASCULAR EFFECTS OF TIMOLOL EYE DROPS IN POOR &EXTENSIVE METABOLIZERS

To determine the effects of greater defects in drug disposition on the cardiovascular effects of timolol of timolol eye drops.